Digital PCR System

Project Summary/Abstract
Cedar Crest College is a small women’s college grounded in the liberal arts, with a strong commitment to
training students in STEM fields. With a student body composed of 43% percent first generation students,
42% students of color, and over 90% of first-year students receiving some form of institutional financial aid
(with 47% of full-time, first-time degree/certificate-seeking undergraduate students receiving Pell grant
assistance), the Department of Biological Sciences believes that using frequent and persistent scientific
research opportunities to engage and train our students is critical for their development as independent
scientists. To this end, the Department is committed to training students in advanced instrumentation within
courses, to incorporating Course-Based Undergraduate Research Experiences (CUREs) in all offered
laboratory courses, and to strongly promoting student participation in independent research opportunities
by all students making academic progress (>90% student participation with an average of 4.7 semesters of
completed research by graduation). To complement available Departmental instrumentation, this proposal
requests funding to support the addition of a Digital PCR (dPCR) system to the Departmental repertoire.
This technology provides a significant advancement in nucleic acid analysis that allows for absolute
quantitation of gene expression and DNA copy number variation, detection, and identification of microbes in
samples, and identification of rare Single Nucleotide Polymorphisms (SNPs). The dPCR technology will be
incorporated into multiple laboratory course offerings including Microbiology, Molecular Genetics I & II,
Advanced PCR Techniques, and Advanced Brain Lab, while also being used in at least four independent
research programs focused on stem cell biology, mechanisms of antibiotic resistance, environmental
microbial monitoring, and characterization of DNA damage repair pathways. Awarding of this grant will
allow the Department to provide more opportunities for student engagement with modern scientific
technology and will help to better prepare our students for success in the workforce post-graduation.

Public health relevance
Project Narrative Cedar Crest College is a women’s college grounded in the liberal arts and populated by a high proportion of first-generation students, students of color, and students requiring financial aid to further their education. To facilitate the transition of these students into the workforce or into graduate programs, the Department of Biological Sciences emphasizes hands-on experience and original research in all lab courses, and students participate in an average of 4.7 semesters of independent research covering topics such as microbiology (antibiotic discovery and resistance), molecular biology (mutation and DNA repair), and neurobiology (cell development and drug response). Digital PCR (dPCR) is a burgeoning technology used in a wide array of studies at different scales, ranging from measuring the activity of individual genes affecting the characteristics of individual organisms to identification of the types of microorganisms in samples, and this breadth of applications will complement current research approaches used by Cedar Crest faculty and students.